IMMUNOLOGIC STUDIES OF HIGH RISK GROUPS

The Family Studies Section (FSS), Environmental Epidemiology Branch (EEB) and the Biochemical Epidemiology Section (BES), Laboratory of Human Carcinogenesis (LHC), Division of Cancer Etiology (DCE), National Cancer Institute (NCI), National Institute of Health (NIH) are contracting with this organization to develop capability in: HLA typing, analysis of cell surface components by flow microflurometry development of hetero and human monoclonal antibodies and implementation of analysis of immune function.